IGF::OT::IGF IMPROVED COMPLETENESS OF TREATMENT AND OTHER KEY DATA ELEMENTS BY LINKAGES WITH 15-MONTH RESUBMITTED DATA FROM COMMITTEE ON CANCER HOSPITALS

The proposed study is designed to determine the extent to which reporting of treatment data by the CoC hospitals would be improved by asking hospitals to resubmit their cases as NAACCR modified (NM) abstract with updated treatment information 15 months after diagnosis. Objectives: 1) After determining case eligibility and conducting manual consolidation, CoC hospitals will be contacted to obtain a resubmission of NM abstracts, 15months after the close of diagnosis year 2014. 2) Case information complete as of January 31, 2016 will be compared to information for the same cases after manual consolidation of the 15 month resubmission data. 3) Analyze the data to determine the percentage of variables that are updated from missing or non-specific codes to known or specific codes, by cancer site. 4) Identify the percentage of cases with updated staging and site specific factor variables, by cancer site. 5) The NM records will be linked based on demographic and site information. 6) The NM cancer records will be imported and flagged with any updated treatment information for the 15-month resubmission. 7) An analysis will be conducted of the complete cases and the CoC resubmitted cases.